Investigating the role of sulfide oxidation and declining hydrogen sulfide in glioblastoma

PROJECT SUMMARY
Glioblastoma (GBM) is a malignant brain tumor responsible for significant morbidity and mortality. Despite efforts
to develop new and more efficacious therapeutic options for GBM, long-term survival rates trail other cancers,
and a diagnosis remains universally lethal. Poor outcomes are the result of many factors, including invasion into
healthy tissue beyond the reach of conventional therapies such as surgery or radiation, cellular heterogeneity
which causes many chemotherapeutic agents to fail, and a highly immunosuppressive environment limiting the
effectiveness of immunotherapy. The inability to improve patient survival is greatly influenced by intrinsic factors
that enable cells to evade death and adapt to a new or changing environment. However, consideration of patient
age as a risk factor provides the greatest predictive value for response to therapy, and disease progression.
While GBM does occur in younger individuals, incidence rates increase with age, and most diagnoses occur in
patients over 65 years. Aging also negatively influences length of survival. Therefore, understanding factors that
contribute to this relationship will improve patient care for the majority of glioblastoma patients. One factor
associated with healthy aging, increased lifespan, and reduced incidence of aging-associated morbidities is a
gas known as hydrogen sulfide (H2S). This sulfur containing gas, recognizable by its rotten egg smell, provides
multiple health benefits at low and supraphysiological levels, but is toxic at extremely high doses. The proposed
studies in this F31 fellowship application focus on the role of H2S in suppressing tumor growth in glioblastoma
and promoting anti-tumor immunity, as well as understanding what role aging has on H2S removal mediated by
sulfide oxidation. Preliminary data indicates that sulfide oxidation is increased in GBM relative to non-malignant
brain tissue and lower grade gliomas. A pattern reflected by decreased survival. Additionally, inhibition of sulfide
oxidation results in decreased proliferation of GBM cells in vitro, likely mediated by the observed decrease in
H2S. Based upon these observations, I hypothesize that sulfide oxidation increases in older individuals, thus
driving the aging-related decline in H2S that enables tumor growth while also promoting an immunosuppressive
tumor microenvironment. I plan to test this hypothesis using two experimental aims. Aim 1 will test the hypothesis
that age-dependent upregulation of sulfide oxidation in GBM leads to reduced H2S signaling and accelerated
disease progression, while simultaneously stimulating mitochondrial electron transport. Aim 2 will test the
hypothesis that declining H2S signaling in aging contributes to immunosuppressive nature of GBM. These aims
will be accomplished using in vitro and in vivo systems for manipulating expression of sulfide oxidizing enzymes
and H2S levels, based upon pharmacological, genetic, and aging approaches. If successful, this project will
elucidate the role of sulfide oxidation in GBM. A previously unexplored pathway that may identify new therapeutic
targets for treating and managing glioblastoma in combination with current standard of care treatments.

Public health relevance
PROJECT NARRATIVE Glioblastoma is a deadly brain tumor with increased incidence rates and decreased survival time post-diagnosis in older individuals. With an aging worldwide population, identification of targetable factors that drive this relationship will be of great significance. Therefore, I propose to investigate the sulfide oxidation pathway observed to increase in the process of aging for its role in depleting tumor microenvironment levels of the glioblastoma suppressive gaseous signaling molecule hydrogen sulfide.